New approaches to study tumor microvesicles

ABSTRACT
Tumor-derived microvesicles (TMVs), a vesicle subtype in the family of extracellular
vesicles (EVs), contain bioactive protein and nucleic acid cargoes and have emerged as
important mediators of intercellular communication in the tumor microenvironment (TME). By
virtue of their roles in the TME, EVs have been thought to support the spread of metastatic
disease by promoting tumor expansion and tumor invasive activity, dampening immune
responses, and facilitating angiogenesis. Thus, identifying and targeting molecules and
signaling pathways that control EV biogenesis and/or function has the potential to lead to novel
and complementary therapeutic strategies. Moreover, the discovery that EVs are found in
circulation has heightened interest in these vesicles as promising diagnostic and prognostic
platforms. Although we have learned a great deal about EV function over the past decade, there
is need to learn much more about how the various EV subtypes are formed and how they
engage and affect recipient cells in the TME. In particular, there is a critical need to define the
cellular pathways and signaling mechanisms that underlie TMV biogenesis to better understand
their paracrine properties and function. Relative to tumor exosomes, the other prominent EV
subtype shed by tumor cells, we know significantly less about TMVs. Our understanding of the
molecular principles that control TMV formation and cargo incorporation remains limited in large
part due to limitations in isolating and precisely defining the molecular makeup of individual EV
populations. To begin to explore the molecular mechanisms of TMV formation and release, we
have adapted a biochemical screen for TMV proteomic studies aimed at identifying TMV-
specific cargo and testing novel regulation of TMV biogenesis. The findings that result from this
pilot study will form the basis of delineating and testing a mechanistic framework underlying
TMV biogenesis and function in preclinical models of tumor progression. Given our experience
and expertise, our laboratory is well position to carry out these investigations.

Public health relevance
PROJECT NARRATIVE Microvesicles are small membrane enclosed sacs shed by tumor cells and a growing body of evidence implicates these vesicles as a novel form of intercellular communication in the tumor microenvironment. However, we only have a rudimentary understanding about the cellular cues that drive their biogenesis, and how they are shed from their parent cells. By investigating the composition of TMVs and mechanisms involved in their release, we expect to gain new insights into TMVs that in turn will inform new strategies for therapeutic intervention.